CaP, crystal responsible for idiopathic nephrolithasis

at the top of each printed page and each continuation page. Type density and size must conform to limits and specifications provided in the PHS 398Instructions. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page 1 Description,